Genome sequencing of foodborne pathogens by the Pennsylvania GenomeTrakr group

Project summary/abstract (Admin) The state of Pennsylvania and its associated GenomeTrakr network has consistently met all obligations of the Food and Drug Administration’s program since joining in 2016. The team, led by Drs. Edward Dudley (Penn State) and Nkuchia M’ikanatha (Pennsylvania Department of Health) have established effective standard operating procedures including the use of controlled documents, to ensure the highest quality data is uploaded to the Pathogen Detection database. This project also has the full backing and access to abundant resources of both organizations, which will continue driving success.

Public health relevance
Project Narrative (Admin) This project describes the team making up the Pennsylvania GenomeTrakr consortium, and protocols in place to ensure completion of the goals established by the United States Food and Drug Administration of populating databases with ever more genome sequences of foodborne pathogens.